SAFETY-A for Promoting Equity in Suicide Prevention Outcomes in Schools

PROJECT SUMMARY
Ethnic minority adolescents, including Asian American and Latinx adolescents are at increased risk for
suicidal thoughts and attempts compared to their Non-Hispanic White (NHW) peers, yet they are less likely to
receive mental health services (MHS) after their suicide risk is identified. Although school-based MHS reduce
access barriers, racial disparities persist within suicide prevention efforts in schools. The proposed study will
adapt Safe Alternatives For Teens and Youth – Acute (SAFETY-A) for implementation in low-resourced school
districts to target putative mechanisms underlying disparities in MHS use following youth suicide risk detection.
SAFETY-A will be adapted to reduce mistrust of MHS, internalized stigma, and concealment of youth
emotional distress that drive poor engagement in MHS among Asian American and Latinx students and
families. Furthermore, SAFETY-A delivery parameters and implementation strategies will be adapted to fit the
organizational context of school district policies and protocols, resource constraints, and workforce needs.
The proposed intervention development study will include three phases. First, stakeholders will be engaged
to design adaptations to the intervention and implementation strategy. Provider, youth and caregiver input will
be gathered using human-centered design approaches to adapting the SAFETY-A intervention content to
address disparities mechanisms. School district leaders, school administrators, and MHS providers will help to
develop a tailored implementation strategy to fit local training and support needs across a range of district
contexts. Second, a prototyping case series will inform iterative refinements of SAFETY-A in one school
district. Third, a pilot controlled trial will randomize school districts to the timing of implementation to provide
preliminary data on the impact of SAFETY-A on proposed mechanisms of action (trust in MHS, stigma, youth
emotion communication) and the primary outcome of MHS utilization and the secondary outcome of suicidal
thoughts and behaviors across racial/ethnic groups. Mixed methods will be used to assess implementation
outcomes of provider adherence, and perceptions of feasibility, acceptability and fit. The proposed project will
provide preliminary data on feasibility and potential impacts on putative mechanisms to propose a definitive
Hybrid Type 1 trial to test SAFETY-A as an intervention to reduce racial/ethnic disparities in MHS utilization
among suicidal youth.

Public health relevance
PROJECT NARRATIVE The proposed study will adapt Safe Alternatives For Teens and Youth – Acute (SAFETY-A) for implementation in low-resourced school districts to reduce racial/ethnic disparities in mental health service use (MHS) following identification of suicide risk in youth. SAFETY-A will be adapted to fit the organizational context of school districts and to reduce mistrust of MHS, internalized stigma, and concealment of youth emotional distress that arise in school suicide risk assessments with Asian American and Latinx students. Following a prototyping case series, a stepped wedge cluster randomized trial will randomize four districts to the timing of SAFETY-A implementation to generate preliminary data on feasibility and impacts on proposed mechanisms and youth MHS utilization and clinical outcomes across racial/ethnic groups.